Defining the role(s) of CGRPα during cutaneous antifungal immunity

PROJECT SUMMARY/ABSTRACT
Invasive Candidiasis (IC) is a life-threatening fungal infection that occurs when Candida spp. invade into deep
tissues and circulation. In patients with an intact immune system, Candida infections are self-limiting. However,
IC presents a serious threat to hospitalized and immunocompromised patients, resulting in ~350,000 deaths
globally each year. The growth of these vulnerable populations and emergence of treatment-resistant Candida
spp. have resulted in an urgent need for novel therapies to improve patient mortality. Recently, it has been
appreciated that nociceptors (pain-sensing neurons) and the neuropeptide Calcitonin gene-related peptide alpha
(CGRP) potentiate antifungal immunity in the skin by a mechanism yet to be defined. Therefore, an improved
mechanistic understanding of CGRP may expand the prophylactic and therapeutic armamentarium for IC.
Based on our preliminary studies, we hypothesize that CGRP is released by nociceptors in the skin and directly
acts on local Dendritic Cells (DC) to induce IL-23 production and Type-17 inflammation. Here we propose 2
specific aims to directly test our hypothesis and characterize the cell-specific direct and secondary effects of
CGRP on antifungal immunity. Aim 1: Determine the obligate source(s) and target(s) of CGRP required
for robust antifungal immunity using a Candida albicans infection model. Subaim 1A: We will ablate
CGRP in cutaneous nociceptors in order to test the requirement of nociceptor-derived CGRP for robust
antifungal Type-17 immunity. Subaim 1B: We will ablate the CGRP-specific receptor subunit (RAMP1) in DCs
in order to test the requirement of CGRP acting on DCs for robust antifungal Type-17 immunity. Through these
subaims we will delineate a cellular circuit responsible for CGRP-mediated antifungal immunity. Aim 2: Test
the functional requirement of CGRP signaling for cellular and transcriptional responses during a C.
albicans infection model by two complementary subaims of single-cell transcriptomics. Subaim 2A: We
will generate chimeric mice reconstituted with congenically distinct RAMP1KO and WT bone marrow progenitors
and perform single-cell RNA-sequencing (scRNA-seq) on immune cells isolated from infected skin. By differential
analyses of RAMP1KO and WT effector populations from the same infection, we will isolate transcriptional
programs downstream of CGRP/RAMP1 signaling. Subaim 2B: We will perform spatial multi-omics analyses
on infected skin from CGRP receptor antagonist- and vehicle-treated mice to test the requirement of
CGRP/RAMP1 signaling for downstream transcriptional, cellular and microenvironment phenotypic changes
during antifungal immunity. We will use single-cell transcriptomics with spatial context to define transcriptional
signatures in situ and cell-cell interactions/communities that depend on CGRP/RAMP1 signaling. Through
these subaims we will characterize the direct and secondary effects of CGRP during antifungal immunity.
Contribution to Training: This proposal combines rigorous training in neuroimmunology, systems immunology
and clinical medicine to aid my development as a future physician-scientist at the forefronts of neuroimmunology.

Public health relevance
PROJECT NARRATIVE Opportunistic and invasive fungal infections (i.e., C. albicans) are remarkably prevalent today and pose a significant threat to hospitalized and immunocompromised patients globally. Although pain-sensing neurons and the neuropeptide CGRP have been implicated as drivers of antifungal immunity, the cell network (i.e., cellular sources of and responders to CGRP) responsible for this pathway remains poorly defined. This proposal will combine the use of mouse models and computational approaches to investigate the role of CGRP during anti- Candida immunity at the skin, with our results paving the way for novel antifungal therapeutics that leverage neuroimmune interactions.